Contrainsulin hormones in production of hyperglycemia

The purpose of this study is to determine whether glucagon, epinephrine and cortisol, singly and in combination and in physiologic doses can produce overt hyperglycemia and the role of these hormones in exacerbating diabetes.